In vivo Wireless Sensors for Gut Redox Monitoring to Understand Host and Microbe Physiology

PROJECT SUMMARY
Non-communicable diseases (NCDs) including obesity, type 2 diabetes, inflammatory bowel diseases
(IBDs), and cancer impose a staggering burden on global economies and quality of life. Evidence is mounting
that many NCDs – particularly those of the gastrointestinal tract – are influenced by the interplay of the
microbiome and the host immune system. A leading hypothesis connecting microbes, lifestyle, and NCDs is that
an unhealthy diet and antibiotic use select for microbes that promote chemical oxidation in the gut. This oxidation
disrupts host and microbiome homeostasis leading to inappropriate, and self-reinforcing, immune and metabolic
dysregulation. However, quantitative hypothesis testing is currently impossible because researchers lack the
necessary tools to directly test gut oxidation in model organisms (rats and mice). Existing data is correlative or
relies on imprecise measures (e.g. genetic ablation and competition experiments) preventing experimental study
of how changes in the microbiota lead to disease.
Our proposal outlines the development of a platform for real-time automated measurement of in vivo
gut oxidation in rodents. The platform comprises implantable / ingestible Oxidation Reduction Potential (ORP)
sensors and a wearable data collection device. ORP is an integrated measure of a chemical environment’s
propensity to lose or gain electrons, or in other words its tendency to get oxidized or reduced. Recent work has
applied ORP sensing to fecal samples from mice and humans, demonstrating ORP changes due to antibiotics
and acute malnutrition. While these results are strongly suggesting of a causative role for gut oxidation in
pathophysiology, the relevance of fecal ORP to gut physiological conditions is unclear.
We propose two major aims for our work to address existing ex vivo technique limitations, and promote
better understanding of gut redox pathophysiology: 1) Develop technology to enable long-term automated in vivo
ORP measurements in awake rodents, 2) determine how changes to the microbiome affect in vivo ORP, and
identify specific chemical correlates of the gut redox state. In achieving these goals, we will use novel ultrasound
wake-up and galvanic coupling technologies to overcome the fundamental challenges of device miniaturization
for implantation in the rodent GI-tract, robustness against animal movement and internal device movement, and
data collection automation for practical, scalable experiments.
This work is significant because new tools to identify impending changes in redox status in the gut are
likely to advance basic science by testing a critical emerging hypothesis in the field. Simultaneously, the
technological advances required for this study make it possible to explore redox patterns for diagnosis, and
strategies for treatment, of diseases associated with redox imbalance, providing significant opportunities for
translational work.

Public health relevance
PROJECT NARRATIVE Aberrant redox signaling has been linked to the development of a wide range of non-communicable diseases including obesity, type 2 diabetes, inflammatory bowel diseases (IBDs), and cancer. Recent research suggests the microbiome plays an important role in disruption of redox homeostasis, but quantitative tools to investigate the mechanisms by which the microbiome contributes to gut and overall host redox state are not currently available. Here we propose wireless devices for monitoring in vivo gastrointestinal tract oxidation-reduction potentials (ORP), as a mechanism for understanding host redox state in model animals and facilitating translation to health monitoring platforms for humans.